Passive Mobile Self-Tracking of Mental Health by Veterans with Serious Mental Illness

Background: Serious mental illnesses are common, disabling, challenging to treat, and require years
of monitoring with adjustments in treatments. Stress or reduced medication adherence can lead to rapid
worsening in symptoms and functioning with consequences that include relapse, job loss, homelessness,
incarceration, hospitalization and suicide. In usual care, clinician visits are infrequent, with intervals ranging
from monthly to yearly. Communication between patients and clinicians between visits is challenging and often
nonexistent. Patient illness exacerbations and relapses generally occur with little or no clinician awareness in
real time, leaving little opportunity to adjust treatments.
Significance/Impact: For the large population of Veterans with serious mental illness, tools are
needed that passively monitor their mental health status, allowing them to self-track their behaviors, quickly
detect worsening of mental health, and support prompt assessment and intervention. At least 60% of Veterans
with serious mental illness use a smart phone. These generate data that characterize sociability, activity, and
sleep. Changes in these behaviors are warning signs of relapse. Passive self-tracking could be used to identify
and predict worsening of illness in real time.
Innovation: Passive mobile sensing is a novel approach to illness self-tracking and monitoring. There
has been relatively little research on passive self-tracking in serious mental illness, with limited analytics
development in this area, and none in VA.
Specific Aims: This project studies passive mobile sensing with Veterans in treatment for serious
mental illness. Data are used for self-tracking of behaviors and symptoms. While passive mobile sensing has
been feasible, acceptable and safe in patients with serious mental illness, these are studied for the first time in
VA. Analytics are developed that use passive data to predict behaviors and symptoms. This project responds to
the HSR&D priority areas of Mental Health and Healthcare Informatics. The project has these objectives:
1. Conduct user-centered design of passive mobile self-tracking to support Veterans’ management of
their mental health.
2. Study the feasibility, acceptability and safety of passive self-tracking of mental health that includes
feedback of mental health status to the Veteran.
3. Use mobile sensor and phone utilization data to develop individualized estimates of sociability,
activities, and sleep as measured by weekly interviews.
4. Study the predictive value of using data on sociability, activities, and sleep to identify exacerbations
of psychiatric symptoms.
Methodology: Activities can be assessed with data on movement, location, and habits. Sociability can
be assessed with data on communication and public interactions. Sleep can be assessed using data on light,
sound, movement, and phone use. Investigators on this project developed “mWellness,” a functional mobile
app that monitors and transmits mobile sensor and utilization data. Focus groups and in-lab usability testing
will inform further app and intervention development. Mixed methods research will study deployment in
Veterans who passively self-track their behaviors and psychiatric symptoms. If this project meets intended
goals, the VA will have a mobile analytics platform that continuously monitors the behaviors and symptoms of
patients with serious mental illness.
Next Steps/Implementation: Results inform development of a study of the effectiveness and
implementation of these methods to improve Veteran assessment, treatment and outcomes. Results are also
applicable to other populations with mental health risk and to the use of similar methods in usual care.

Public health relevance
Serious mental illnesses require years of monitoring and adjustments in treatment. Stress, substance abuse or reduced medication adherence cause rapid worsening of symptoms, with consequences that include job loss, homelessness, suicide, incarceration, and hospitalization. Treatment visits are infrequent. Illness exacerbations usually occur with no clinician awareness, leaving little opportunity to make treatment adjustments. Tools are needed that quickly detect illness worsening. At least 60% of Veterans with serious mental illness use a smart phone. These phones generate data that characterize sociability, activity and sleep. Changes in these are warning signs for relapse. Members of this project developed an app that monitors and transmits these mobile data. This project studies passive mobile sensing that allows Veterans to self-track their activities, sociability and sleep; and studies whether this can be used to track symptoms. The project intends to produce a mobile platform that monitors the clinical status of patients, identifies risk for relapse, and allows early intervention.